Cancer Prevention and Control

PROJECT SUMMARY/ABSTRACT - CANCER PREVENTION AND CONTROL (CPC)
The mission of the Cancer Prevention and Control (CPC) Program at the University of Chicago Medicine
Comprehensive Cancer Center (UCCCC) is to: (1) promote novel cancer population science discoveries
through interdisciplinary research; (2) develop efficacious and disseminable interventions that prevent
cancer, detect it early, or improve survivorship; and (3) translate this knowledge into clinical and public
health practices that benefits our catchment area and beyond. The CPC program promotes research and
translational efforts with a strong emphasis on fostering collaboration across UCCCC research programs;
training the next generation of scientists; engaging local communities; and supporting diversity, equity, and
inclusion efforts. Reducing or eliminating cancer disparities in our catchment area, nationally, and globally
is an overarching premise across all CPC activities. The CPC Program consists of 38 scientists from 10
Departments across the University, who are supported by strong NIH ($7.6M) funding, including $4.7M from
NCI and have been highly productive during this funding cycle (752 publications, 22% in high-impact
journals). Guided by UCCCC strategic priorities, CPC leaders promote research and collaboration by
organizing working groups and retreats, supporting pilot projects, shaping UCCCC Shared Resources,
contributing to faculty recruitment, and providing mentorship opportunities. Investments support novel CPC-
relevant research infrastructure at the local, national, and international levels, including creation of
demographically and socio-economically diverse cohorts, case-control studies of diverse ancestries, and
biomedical data commons. To continue to build upon and extend the program’s accomplishments, resources,
and expertise, we propose the following complementary aims that span the cancer control continuum. Aim
1: to investigate environmental, lifestyle, genetic, and socio-structural factors to mechanistically understand
how they cause and increase risk of cancer. Aim 2: to develop, test, and implement novel interventions for
primary prevention and early detection of cancer in healthy populations. Aim 3: to assess determinants of
survivorship and develop interventions that (a) optimize delivery of precision oncology, (b) enhance health-
related quality of life, and (c) improve outcomes among cancer survivors. Our aims align with 4 UCCCC’s
Strategic Pillars: (#1) reduce the catchment area’s cancer burden and disparities, (#4) develop novel imaging
modalities to optimize screening, (#6) leverage epigenetics to understand cancer mechanisms, and (#8)
foster inter-programmatic interactions. Guided by these aims and priorities, the collective impact of CPC
members is on a strong, upward trajectory with future plans focused on (1) working with the COE Office to
embed intervention and implementation scientists in healthcare and community settings to ensure strategies
are sensitive to local contexts, and (2) testing novel health communication interventions to enhance
dissemination of CPC discoveries and impact health policies and clinical practice.